Mitochondrial Biology

ABSTRACT Support is requested for a Keystone Symposia conference entitled Mitochondrial Biology, organized by Drs. Jodi Nunnari, Anu Suomalainen-Wartiovaara and Koji Okamoto. The conference will be held April 22-26, 2018 at The Westin Miyako in Kyoto, Japan. Mitochondria perform fundamental diverse functions in eukaryotic cells, including ATP production and ion and phospholipid homeostasis. They also serve as platforms to integrate signaling pathways and cellular processes, such as innate immunity and autophagy. Mitochondrial functions are tightly linked to mitochondrial form, which is established through coordinated machines that control dynamics, positioning, motility and mitochondrial DNA transmission. Contact sites between mitochondria with diverse organelles have emerged as key and pervasive regulators of mitochondrial form and function. These contact sites, as well as metabolites, fully integrate mitochondria into the cell and organism. It is therefore not surprising that mitochondrial dysfunction has emerged as a key factor in a myriad of diseases, including neurodegenerative and metabolic disorders. This conference will provide a cutting-edge view of how mitochondrial form and function is controlled and how its myriad of functions impinge on health and disease.

Public health relevance
PROJECT NARRATIVE Despite intensive research, effective treatment for most types of metastatic tumor remains elusive and cancer perseveres as the second leading cause of death in the United States, as well as, a leading cause of mortality worldwide. This conference is being held jointly with Selective Autophagy and will bring together researchers focused on mitochondrial biology and autophagy, with a special and logical emphasis on metabolism and interorganellar communication, and pharmaceutical development to exchange perspectives. Through this meeting, we will have a better understanding of the roles of these processes in cancer to foster new therapeutic progress.